Children's Mercy Hospital Collaborative Fellowship Program in Pediatric Pharmacology

Abstract
The Division of Clinical Pharmacology, Toxicology, and Therapeutic Innovation at Children’s Mercy Hospital
(CMH) in Kansas City, offers one of the largest, most diverse, Pediatric Clinical Pharmacology post-doctoral
training programs in the U.S. It is constituted by 20 faculty including 1) clinicians cross-trained in Allergy/
Asthma/Immunology, Behavioral Medicine, Cardiology, Environmental/Occupational Health, Gastroenterology,
Hematology/Oncology, Infectious Diseases, Maternal/Fetal Medicine, Neonatology, Nephrology, Nursing,
Pharmacy, Rehabilitation Medicine, and Toxicology, along with 2) basic/translational scientists with experience
in analytical chemistry, genetics, genomics, in vitro biotransformation, and molecular biology. Affiliated faculty
contribute additional expertise in the areas of Bioethics, Bioinformatics, Health Outcomes, and Pharmaco-
epidemiology. The program has made substantial contributions in the areas of pharmacogenetics, pharmaco-
metrics, and early phase clinical trial design. The program combines robust didactic and experiential training in
pharmacogenetics/genomics, metabolomics, pharmacometrics, pharmacoepidemiology, drug development,
and the responsible conduct of research. It also offers unique elective opportunities dedicated to pediatric
PBPK-based modeling and simulation (Simcyp/Certara), pediatric regulatory review and approval (FDA),
bioinformatics (PharmGKB), Formulary management (CMH/Medicaid), and adult pharmacology (Mayo). Two
independent Masters programs offered by affiliated medical schools round out the academic program at CMH.
All teaching is accomplished by faculty with significant research experience in their respective subject areas.
Trainees affiliate with the program for a minimum of three years; the first two years in Clinical Pharmacology
are blended with the second and third years of their subspecialty training and their third year is dedicated to
clinical pharmacology. Under the direction of a junior mentor, a senior mentor, and a scholarship oversight
committee, fellows complete both a clinical and translational research project, produce several publications/
presentations, compete for a minimum of one research grant, and develop a plan to transition to independence
prior to graduation. Quality is continually assured by a robust evaluation strategy and diversity is supported by
a comprehensive recruitment strategy. Since its inception, the program at CMH has trained 24 pediatric clinical
pharmacology fellows (17 pediatricians, 6 pharmacists, 1 nurse; 14 female, 2 African American, 1 Hispanic, 1
Native-American, 3 Asian) who during their fellowship period have collectively delivered 118 scientific
presentations, prepared 102 peer-reviewed manuscripts and successfully competed for over $1,500,000 in
intramural and extramural funding. The program is one of only three American Board of Clinical Pharmacology
accredited training programs dedicated solely to Pediatric Clinical Pharmacology and its longstanding record of
excellence provides applicants with unparalleled training in the discipline.

Public health relevance
Project Narrative Clinicians trained in the discipline of pediatric clinical pharmacology remain instrumental to the acquisition, adoption, and implementation of knowledge that guides the safe and effective use of medicines in children. Formal training in clinical pharmacology arms individuals with the skills necessary to 1) integrate the basic and clinical sciences, 2) design and analyze clinical trials, 3) characterize therapeutic outcomes and/or relevant surrogate biomarkers, and 4) define dose-exposure-response relationships. The program at Children’s Mercy, which accepted their first fellow in 1998, provides an exemplary environment in which to train the next generation of pediatric clinical pharmacologists and remedy the shortage of clinician scientists who have formal training in this discipline.